Advancing Epigenetic Sequencing Through Solid-Phase Enzymatic Approaches

PROJECT SUMMARY
Modifications to cytosine bases within DNA play an important epigenetic role in shaping cellular identity and fate.
In mammalian genomes, the most abundant of these modifications is 5-methylcytosine (5mC), which has been
linked with gene silencing. A landmark moment in the field came from the discovery of TET enzymes, which
iteratively oxidize 5mC to yield 5-hydroxymethylcytosine (5hmC) and more highly oxidized 5mC bases. In
contrast with 5mC, 5hmC has been associated with gene activation, highlighting the importance of resolving
different DNA modification states. Given their biological significance, localizing modified bases within genomes
has been a major focus for the field. Epigenetic sequencing approaches can elucidate biological roles for DNA
modifications and can identify aberrant modifications that contribute to disease. The traditional method for
pinpointing cytosine modifications involves reacting sample DNA with bisulfite to selectively deaminate
unmodified cytosines, while preserving 5mC and 5hmC. While foundational, bisulfite can fragment DNA, raising
challenges with input DNA requirements, and the method confounds 5mC and 5hmC. Newly established
enzymatic methods are non-destructive, but still confound multiple bases and require excessive purification steps
that result in loss of DNA. This study aims to develop an enzymatic method for epigenetic sequencing of
solid-phase immobilized DNA, enabling quantitative capture of input DNA and resolution of modification
states, thus allowing for insightful sequencing to be conducted on limiting samples. Aim 1 proposes the
development, benchmarking, and application of the method to study how TET1 reshapes the epigenome in
primordial germ cells, a sample where analysis is limited by low sample quantities. After initially establishing a
solid-phase enzymatic method for epigenetic sequencing, this study will subsequently leverage solid-phase
enzymatic principles and multiplex them with chemical conversion to develop a method for resolving C,
5mC, and 5hmC in the same DNA molecule. Aim 2 proposes the development of an unprecedented method
capable of both locating and identifying epigenetic modifications in cis. Following method development and
validation, this method will be applied to study the Foxp3 locus where 5mC/5hmC modification dynamics are
known to play deterministic roles in regulatory T cell identity, but current methods cannot to parse cis modification
relationships. Overall, the two novel methods developed in this proposal will be applied with a focus on biological
insights and position the field for future applications aimed at resolving epigenetic abnormalities that can be a
hallmark of disease states. This training plan will prepare the PI for an independent research career investigating
epigenetic drivers of disease and will take place at the highly interdisciplinary University of Pennsylvania.

Public health relevance
PROJECT NARRATIVE Chemical modifications to DNA impact biological function, and when they deviate from the norm, it can lead to disease. This study aims to develop biotechnological methods to precisely map these epigenetic DNA modifications under challenging scenarios, when either sample amount is limited or diverse modifications within a sample are clustered. These methods will advance our understanding of developmental biology and lay the groundwork for future applications in the study of disease progression.